Pulmonary Diseases in WTC Workers: Symptoms, Function, and Chest CT Correlates

Project Summary
Our long-term goal has been to characterize the heterogeneous group of chronic lower airway
diseases (LAD) observed in World Trade Center (WTC) workers and volunteers, uncover their risk factors and
comorbidities, identify subgroups with adverse and favorable lung function trajectories and outcomes, and
develop and deploy novel imaging approaches to the investigation of the lung injury underlying them. Such
goal will in turn translate into better understanding of disease pathophysiology, more targeted,
personalized, and perhaps disease modifying treatment approaches, and improved surveillance and
prevention strategies.
Our previous studies established valid clinical diagnoses and have demonstrated markedly diverging
longitudinal lung function trajectories in the largest and most diverse WTC occupational cohort. Besides our
expertise with longitudinal lung function analyses, we were uniquely able to demonstrate associated
quantitative chest computer tomography (QCT) metrics that have helped validate and characterize the
disease processes that have been associated with WTC occupational exposures. QCT has revolutionized
respiratory research, and has contributed important and novel information on interstitial, proximal and
distal airway, and vascular changes that underlie the process of inflammatory remodeling and disease
progression. Our observations in this cohort have also identified a subgroup who has experienced
unexpected and significant lung function gain in adult life, suggesting a process of resolution in need of
improved understanding. Our studies have been on the forefront of occupational respiratory research.
We propose three specific aims to deploy novel QCT and spirometric markers to investigate early
interstitial and airway injury and remodeling in subjects who have experienced accelerated lung function
decline or developed chronic obstructive pulmonary disease while on longitudinal and clinical surveillance.

Public health relevance
Project Narrative Utilizing an extensive amount of qualitative and quantitative imaging, clinical, and functional data, we propose to investigate newly developed and novel chest CT scan imaging and spirometric markers to the investigation of lung tissue and airway injury and remodeling, and its evolution over time towards healing and recovery, or to chronic and disabling chronic lung disease. These investigations have the potential to enhance our ability for earlier and more effective detection or treatment, and to prevent disability.